Deep-learning methods based computational modeling

Project summary
Recent advancements in deep learning-based computational protein structure prediction by
AlphaFold, RoseTTAFold, ESMFold, and OpenFold methods offer promising opportunities to
advance our ongoing NINDS-funded research project entitled “Activation and Inhibition
Mechanisms of Calcium-Activated Nonselective Cation Channels” (1R01NS128180). We plan to
use current and future deep learning-based computational protein structure prediction methods
to predict gating conformational changes in TRP channels with high accuracy to complement
our functional studies. We aim to capitalize on these opportunities with this administrative
supplement. To fully utilize the extensive capabilities of deep learning-based computational
protein structure prediction method capabilities, powerful computational resources are needed
with advanced GPU, CPU, RAM, and disk capacity.
We are requesting $50,000 NINDS supplement funding to purchase an AI system capable of
running all current and future deep learning-based computational protein structure prediction
methods. We have identified the ideal AI system configuration from Bizon Technostore. A quote
is submitted together with this application.

Public health relevance
Project narrative An AI system is requested to allow us to take full advantage of the latest advancements of computational biology in support of our ongoing research project.